The Role of Lipid-specific T cells in Mediating Protection Against M. tuberculosis

PROJECT SUMMARY
Several lines of evidence from human and animal studies have revealed the critical importance of T cells
in conferring protective immunity to Mycobacterium tuberculosis (M.tb). However, we still do not know which M.tb
antigens are targeted by the T cells that confer protection. This information is critical to developing new subunit
vaccines that are more effective than Mycobacterium bovis bacille Calmette-Guérin (BCG), which is currently
the only licensed vaccine for tuberculosis (TB). Classically, T cells are activated by foreign peptide antigens that
are bound to highly polymorphic major histocompatibility molecules. Alternatively, mycobacterial cell wall lipids
have conclusively been shown to activate human T cells when bound to non-polymorphic CD1 proteins on
antigen-presenting cells. The CD1 system mediates protective T-cell responses in mouse models of
autoimmunity, cancer, and infectious diseases. However, the lack of an appropriate animal model has impeded
research into the importance of CD1-restricted T cells in the pathogenesis of M.tb. Tools to identify CD1-
restricted T cells were also unavailable until recently. We have established lipid-loaded CD1 tetramers as tools
to study the phenotypes and functions of CD1-restricted T cells in humans and non-human primates. We have
also developed and validated a humanized CD1 transgenic (hCD1Tg) mouse model and shown that T-cells
specific for mycolic acid, a major constituent of the mycobacterial cell wall, confer protective immunity to M.tb
challenge. Finally, we have developed a lipid-based nanoparticle vaccine and shown that it induces durable T
cell responses to mycolic acid in hCD1Tg mice. In Aim 1 of this renewal application, we will determine how lipid
chain length, alveolar macrophages, and dendritic cells modulate T cell responses induced by nanoparticle
vaccination. In Aim 2, we will use lipid-loaded tetramers to define the phenotypes and functions of CD1-restricted
T cells in rhesus macaques after intravenous BCG vaccination, which confers sterilizing immunity to M.tb
challenge. We will also use quantitative PCR to enumerate CD1-restricted T cells in pulmonary granulomas and
correlate this with bacterial burden. In Aim 3, we will determine the role of CD1-restricted T cells in mediating
control of M.tb infection in hCD1Tg mice using adoptive transfer of transgenic T cells as well as a BCG prime
and nanoparticle boosting vaccine regimen. Finally, we will leverage a tonsil organoid model of human
tuberculosis to determine whether human CD1-restricted T cells are activated and express anti-bacterial effector
functions after M.tb infection as well as control bacterial replication. By the end of the funding period, we will
have defined the role of CD1-restricted in M.tb pathogenesis and provided the rationale for whether lipid-specific
T cells should be considered a correlate of protective immunity in ongoing Phase II/III clinical efficacy studies of
whole cell mycobacterial vaccines.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis (M.tb), the cause of human tuberculosis, is largely composed of waxes (lipids) that our immune system “sees” with the help of T cells. Whole cell mycobacterial vaccines currently under development also contain these lipids, but we do not yet know if lipid-specific T cells contribute to protective immunity induced by vaccination. Here, we will leverage tools we have developed to study these T cells in animal models and human organoids to test the hypothesis that lipid-specific T cells provide protective immunity against M.tb.